New pharmacological tools to explore platelet GPR56 function

Platelets are small cell fragments that circulate in the blood and their activation is critical for the
blood clotting response. Initial platelet activation results from interactions with the collagen sub-
layer that becomes exposed to the blood stream following blood vessel injury. Patients who have
platelets with impaired receptiveness to collagen have severe bleeding disorders. Recently, we
discovered that GPR56 (ADGRG1), a collagen-sensitive adhesion G protein-coupled receptor
(AGPCR), is present on the surface of platelets and mediates their activation mechanism.
AGPCRs are an understudied 33-member subfamily of GPCRs characterized in part by a bulky
extracellular domain. Knowledge of how AGPCRs operate in vivo has stagnated due to a lack of
available probe compounds. Consequently, I am finishing up large high throughput screens to
identify novel small molecule activators and inhibitors of GPR56. Use of these compounds will
expand our knowledge of both platelet biology and the AGPCR mechanism through my
pharmacological investigation of GPR56 signaling in platelets. I propose two aims to advance
knowledge of how GPR56 works in the platelet system: (1) Validate the new GPR56 activators
and inhibitors found in my screens, and (2) utilize GPR56-specific compounds to assess how
GPR56 mediates platelet signaling. Aim 1 will be accomplished using a battery of established
cell-based and biochemical assays to measure GPR56 signaling. Aim 2 will examine the effects
of GPR56 modulatory compounds in ex vivo human and mouse platelet assays. Blood clotting
(thrombosis) is implicated in a large portion of deaths. My studies will not only provide critical
insight into how blood clotting is regulated, but may also yield new classes of lead compounds
that might be used to treat hematological diseases.

Public health relevance
Project Narrative GPR56 is a G protein coupled receptor recently discovered to be present on the surface of platelets, which are responsible for forming blood clots (hemostasis). We have found that this receptor strongly influences how platelets can activate and cluster to form clots. By pharmacologically studying how GPR56 regulates platelet activation, we will greatly expand our knowledge of hemostasis in humans.